The Paycheck Protection Program and its Effects on Staffing Patterns and the Outcomes of Residents Living with Dementia

PROJECT SUMMARY/ABSTRACT
.
Nursing home staff shortages are well known to be an important factor impacting both the quality of care that
nursing home residents receive, their health outcomes, and healthcare worker outcomes. Staffing shortages are
compounded by limited financial resources in nursing homes, especially for smaller nursing homes, which was
further exacerbated by the COVID-19 pandemic. These staffing shortages disproportionately impact nursing
home residents living with Alzheimer’s disease and related dementias (ADRD) as they require more time from
staff compared to care for residents who do not have ADRD. As the number of Americans living with ADRD
increases, the need for fully staffed nursing homes that can provide quality care for older adults living with ADRD
is now more important than ever.
During public health emergencies, direct funding to nursing homes has been proposed as an expedient way to
prevent staffing losses and maintain safety standards for residents. One federal policy mechanism utilized by
nursing homes during the COVID-19 pandemic was the Paycheck Protection Program (PPP). The PPP loan
program offers a unique natural experiment by which to evaluate the effectiveness and efficacy of a program
that directly funds small businesses and in the case of this project, nursing homes, to maintain safe staffing
levels during public health emergencies. While PPP loans were effective overall at keeping workers on the payroll
across all US small businesses, it is unclear if the effects of the program were equitable across nursing homes
in socioeconomically deprived neighborhoods which prior work from our team showed have lower staffing rates.
Using robust econometric methods and an exploratory sequential mixed methods approach, the proposed
project will assess the effectiveness and equity of PPP funding by 1) examining changes in staffing patterns and
resident outcomes among nursing homes that received the PPP loans compared to nursing homes that did not
and evaluating whether changes in staffing patterns and outcomes were equitable for those with ADRD living in
the most socioeconomically deprived facilities; 2) qualitatively exploring facility strategies, tools, and social
contexts that promoted resilience to declines in staffing and ADRD resident outcomes after receipt of PPP, and
3) quantitatively assessing the extent to which resilience strategies, cultures, and behaviors identified in Aim 2
are reflected in administrative actions about staffing and care for residents with ADRD, and how actions differed
by neighborhood context. The overall goal is to develop a framework by which to guide future nursing home
responses to public health emergencies that will improve staff patterns and subsequent ADRD outcomes in the
most socioeconomically deprived/lowest-resourced neighborhoods.

Public health relevance
Project Narrative Maintaining safe nursing home staffing levels during public health emergencies is of critical importance to the growing population of residents living with Alzheimer’s disease or related dementias. Our proposal seeks to understand the effectiveness and equity of federal emergency funding that directly supports nursing home staffing, with an overall goal to develop a framework by which to guide future nursing home responses to public health emergencies.